Identification of treatment parameters that maximize language treatment efficacy for children.

Abstract Poor language skills are associated with numerous negative outcomes ranging from higher rates of tantrums and difficulty developing friendships to school failure, contact with the justice system, and increased victimization. Although language deficits may be noticed as early as toddlerhood, effective treatment may not begin this early and there is relatively little time to close the language gap before these children are faced with the increased language demands of formal education and the cumulative effects of academic struggle. For the 7-13% of children with impaired language skills, language treatments that are faster and more effective are urgently needed. This competing renewal addresses this need with a series of studies that translate basic research in statistical learning to treatment contexts. The Statistical Learning Framework posits children extract word meaning and grammatical structure from the distributional information contained in the language input they receive and accounts for rapid implicit language learning. The proposed studies take an experimental approach in which theoretically-motivated treatment factors are tested in two groups of children with poor language skills. “Late Talkers” are children (ages 2-3 years) who are identified by their very limited number of vocabulary words that they know and use. Preschool children with Developmental Language Disorder (ages 4-5 years) show marked deficits in the use of grammatical morphemes. We will directly address the issue of non-responders (i.e., children who make limited improvement despite treatment that is effective for others), a problem inherent to all treatment research. We leverage our previous findings to predict early in the treatment process which children are highly likely to be non-responders and propose an alternative treatment method that might be better suited to this subset of children. These studies represent the necessary work for principled language treatment that is supported by evidence, and can provide insights into the nature of learning in a range of children with poor language skills.

Public health relevance
Health relevance: Despite forty years of research on language impairments in children, information on effective treatment is sparse. The proposed studies evaluate treatment methods for vocabulary and morphosyntax deficits. The results should yield treatment procedures that can be imported into clinical practice.